Implementation of PrEP Care Among Women in Family Planning Clinics

PROJECT SUMMARY/ABSTRACT
Cisgender Black women are frequently overlooked in HIV prevention efforts even though they have one of the
highest incidences of HIV among all subpopulations, second only to men who have sex with men. Pre-exposure
prophylaxis (PrEP) is a safe and effective daily medication for those at risk for HIV infection. However, data
indicates a substantial inequity in PrEP use among women compared to their need. This proposed study will
evaluate implementation strategies to address multi-level barriers and increase uptake of PrEP among
Black cisgender women in Planned Parenthood clinics in Illinois.
Our team’s preliminary work has identified successful strategies for PrEP Optimization among Women to
Enhance Retention and Uptake (POWER Up). POWER Up implementation strategies address key barriers to
PrEP uptake and include: 1) routine PrEP education 2) standardized provider training, 3) electronic health record
(EHR) tools; and 4) PrEP navigation. These strategies have not been studied in family planning clinics with a
large population of Black cisgender women. Therefore, using implementation science research methods, we
propose to implement and evaluate the impact of the POWER Up strategies within the Planned Parenthood of
Illinois (PPIL) health center setting to improve PrEP care continuum outcomes for Black cisgender women. By
implementing POWER Up strategies in PPIL health centers we seek to address the gap in knowledge in
identifying effective strategies to increase uptake of PrEP among Black cisgender women.
This proposed study aims to:
1. Adapt POWER Up implementation strategies for engaging Black women in the PrEP care continuum in
eight Planned Parenthood clinics in Chicago
2. Determine the effectiveness of POWER Up across eight PPIL sites within Chicago’s high prevalence HIV
areas; and,
3. Assess and document implementation outcomes and report on key barriers and facilitators related to successful
implementation of the intervention
Findings from this study will provide insight into implementation strategies that can support effective replication
across the 800 Planned Parenthood health centers and other health centers providing family planning services
nationwide to reach a greater number of women at risk.

Public health relevance
PROJECT NARRATIVE Family planning clinics are a primary source of health care access for women, providing an ideal opportunity to integrate HIV prevention efforts (e.g., pre-exposure prophylaxis (PrEP) information and care) into existing clinic practices. Through preliminary work, we have identified successful strategies to increase PrEP uptake among Black cisgender women. Using a stepped-wedge hybrid trial, we will implement these strategies within the Planned Parenthood of Illinois health center setting to improve PrEP care continuum outcomes among this population with the goal of reducing new HIV infections among women and contributing to efforts to End the Epidemic.